Kansas PKD Research and Translation Core Center - Administrative Core

Project Summary - Administrative Core
The mission of the Kansas PKD Research and Translation Core Center (RTCC) is to promote PKD
research by providing essential reagents, biomaterials, and service to the PKD research community for the
advancement of our understanding of disease mechanisms, the discovery of biomarkers and therapeutic targets
and the development of clinical trials to improve patient outcomes. The mission of the Center is based on
research at Kansas that discovered and characterized many of the key pathways now being considered for PKD
therapy, and that ultimately led to the development of Tolvaptan as the first FDA approved therapy for ADPKD.
The Kansas PKD RTCC has created three biomedical research cores to support the research programs of
external core users in the PKD Research Consortium and the greater PKD research community. These cores
are: Core 1. Biomarkers, Biomaterials, and Cellular Models (Darren Wallace, Director), Core 2. Rodent Models
& Drug Testing (Pamela Tran and Stephen Parnell, Co-Directors), and Core 3. Clinical Research (Alan Yu,
Director). The Administrative Core will be responsible for setting the overall scientific direction of the Kansas
PKD Center, overseeing core activities, and for prioritizing the distribution of resources to each of the cores. The
Administrative Core will also be responsible for organizing a variety of educational enrichment activities, including
a Summer Student Enrichment Program, PKD research methods workshops, professional development
sessions, Research Methods and Advanced Technologies Program, research seminars, retreats, patient-
oriented activities, and will work with the Central Coordinating Site (CCS) on the annual symposium. The
Administrative Core has an Internal Advisory Committee (IAC) comprised of the center directors and core
directors and established KUMC scientists outside the PKD field who will bring their expertise to the committee,
plus a representative from the PKD patient community to serve as a patient advocate. All PKD Core Center
activities will be regularly reviewed and evaluated by the Internal Advisory Committee for communication to the
CCS Steering Committee, the External Evaluation Panel (EEP), and NIDDK. The Administrative Core will support
the recruitment of new investigators into the PKD field through various mechanisms including an innovative
internal pilot grant program in partnership with the KU Cancer Center to support research projects exploring the
relationship between PKD and cancer. Finally, the Administrative Core will work to promote strong interactions
between the Kansas PKD Center and the institution by interfacing its activities with other programs, centers, and
institutes at KUMC, and by integrating the biomedical research cores with existing institutional shared resource
centers and biomedical cores; and will encourage open and frequent communication with the CCS and with the
other national PKD RTCCs to maximize the benefits offered by our unique, high-value core services to the
national PKD community.